Post-transcriptional regulations of proteomes in stress and senescence

Project Summary
This administrative supplement application is being submitted to PA-20-272 in accordance with NOT-GM-22-
017. The scope of the parent project R01-GM144456 will not be changed. The requested supplement will replace
critical hardware infrastructure to accelerate our research with modern capabilities and permit increased
productivity. Parent Project Summary: Post-transcriptional mechanisms play a fundamental role in regulating
gene expression at the protein level, and are frequently implicated in stress response, aging, and diseases. The
goal of this project is to develop and apply multi-omics methods to examine the post-transcriptional
mechanisms that regulate protein composition of multiple tissues and their ability to respond to intrinsic and
environmental proteostatic stressors. In recent work, our team has developed mass spectrometry and multi-
omics methods that are designed to elucidate the protein isoform composition and spatiotemporal dynamics.
Building on these progresses, we will focus here on the roles of three post-transcriptional mechanisms known
to influence protein translation in stress response. Specifically, Aim 1 will integrate proteomics and
transcriptomics data to identify the role of alternative splicing in modulating principal isoform abundance,
creating alternative proteoforms, and influencing protein localization across tissues (heart, lung, muscle, brain),
sexes, and lifespan. Aim 2 will determine the differential expression, localization, and targets of RNA-binding
proteins in proteostatic stress responses to intrinsic or extrinsic stressors including paraquat in vivo as well as
doxorubicin and hydrogen peroxide in vitro. Finally, Aim 3 will examine the configuration and interactome of
the translation apparatus including the core ribosome and an increasing number of known ribosome-
associated proteins, which have emerged as important factors that can fine-tune the translational efficiency of
individual transcripts and the associated protein synthesis rates. The proposed experiments will interrogate the
relationships between post-transcriptional regulation and stress response, and at the same time generate novel
data sets including isoform-resolved, spatiotemporal atlases of the normal, stressed, and aged/senescent
proteomes. We anticipate the results will lead to novel insights into basic cellular processes of stress response
and resilience that will be relevant to studies of multiple systems.

Public health relevance
Project Narrative Cellular function requires the capacity to maintain physiological protein compositions and respond to environmental stimuli. The proposed project will apply large-scale mass spectrometry and proteomics technologies to examine post-transcriptional mechanisms that regulate protein composition and synthesis in mammalian tissues as well as human cell culture models. The results will advance current understanding of how tissues and organisms mount successful responses to oxidative stressors or lose resilience and develop diseases.